Late-stage development and de-risking of a novel monoclonal antibody immunotherapy for EGFR-positive solid cancers

Abstract
The primary objective of this project is to develop therapeutic IgA to uniquely harness the tumor cytolytic potential
of neutrophils to target EGFR-mutant non-small cell lung cancer (NSCLC), thereby enabling these patients to
live better, longer lives. Toward this goal, TigaTx is developing TIGA-001, a first-in-class, IgA-based monoclonal
antibody treatment for advanced/metastatic EGFR-positive NSCLC, with plans to initiate a first-in-human clinical
trial. TigaTx has generated a robust data package around the TIGA-001 molecule, leading to its selection as our
first development candidate. TIGA-001 has demonstrated excellent in vitro potency and in vivo efficacy, and is
well tolerated in non-human primates with favorable safety and pharmacokinetic profiles. TIGA-001 utilizes our
patented, structure-driven protein engineering to overcome the known manufacturing liabilities of natural IgA,
enabling us to be the first to transform IgA into a clinically-relevant platform technology. In this project, we will
progress our TIGA-001 candidate into CMC activities, in vitro pharmacology, and biomarker identification and
assay development to support filing of an Investigational New Drug application with the FDA. Supported CMC
activities will consist of vector generation through master cell bank establishment. Supported pharmacology
studies will focus on in vitro safety assessment and studies to support GLP toxicology species selection.
Biomarker assays developed from these studies will be incorporated into our first-in-human clinical trial to
evaluate dose-PD response relationships, enable patient selection/enrichment, and otherwise inform clinical
strategy. Because therapeutic IgA is a platform technology with potential to target a wide variety of tumor-
associated antigens, demonstrating clinical proof of concept with our TIGA-001 program would not only benefit
patients with EGFR-expressing tumors, but would also open the door to using this approach against other targets
in a wide range of additional clinical settings.

Public health relevance
Narrative TIGA-001 is being developed as a first-in-class, IgA-based monoclonal antibody immunotherapy treatment for advanced/metastatic EGFR-positive Non-small cell lung cancer (NSCLC), the leading cause of cancer death in the United States. TIGA-001 harnesses the cytotoxic potential neutrophils as novel effector cells to drive IgA- mediated antibody-dependent cellular cytotoxicity of EGFR-positive tumors, and has been designed to overcome several of the critical limitations of currently approved or investigated therapies. This project will progress towards the clinic as a promising therapy for NSCLC patients who are resistant to standard-of-care therapy, providing potential for significant improvement in patient survival and quality of life.